Cardiovascular Scientist Training Program

Description (provided by applicant): The training program described in this renewal application represents a new paradigm for training academic cardiologists as cardiovascular scientists, based on the UCLA STAR (Specialty Training and Advanced Research) Program combining clinical subspecialty training with research training leading to a Ph.D. or Masters degree. This program has been in existence here at UCLA for over 13 years and has trained over 15 cardiovascular scientists and researchers. M.D. trainees will complete 2 years of subspecialty cardiology training and 3-4 years of research training that fulfills the requirements for a Ph.D. degree in Public health or one of the~basic sciences or a Masters of Clinical Investigation, including formal course work and research leading to successful thesis defense. M.D./Ph.D. trainees undergo 2 years of post-doctoral research training, including elective course work. Eight positions are requested, to provide support for the research training component only. The training faculty consists of 34 senior preceptors and 15 supporting faculty. Only senior preceptors may serve as primary research mentors, and they come from 5 groups: the UCLA Cardiovascular Research Laboratory, the UCLA Atherosclerosis Research Unit, the UCLA ACCESS Program (a multi-departmental program administering Ph.D. training in life sciences), the School of Engineering, and, for health services research, the UCLA School of Public Health and RAND Graduate School. Supporting faculty do not act as primary mentors, but play a key role in enhancing the overall research environment and fostering translational research from the basic to the clinical arena. The research programs of the faculty are supported by over 39 million dollars in direct costs annually from extramural sources. By integrating cardiology subspecialty training with the formal recruitment of Ph.D. training (or equivalent post-doctoral training for those already having a Ph.D.), the UCLA Cardiology STAR Program provides graduates with the rigorous research background essential to translate the unparalleled advances in molecular health sciences into modern molecular medicine. RELEVANCE (See instructions): i The UCLA Cardiovascular Scientist Program is specifically designed to combine comprehensive research training leading to a Ph.D. degree or equivalent with subspecialty training in clinical cardiology for MDs. The goal of this program is to provide cardiologists with highly competitive research training, allowing them to translate advances in basic research to the clinic, or to address health service issues critical to society.